BIOANALYTICAL/PHARACOKINETIC SHARED RESOURCE

PROJECT SUMMARY (See instructions): The Bioanalytical/Pharmacokinetics Shared Resource (BPSR) is a shared resource that provides Knight members with access to state-of-the art liquid chromatography tandem mass spectrometry (LC-MS/MS) and gas chromatography mass spectrometry (GC-MS). The BPSR provides expert consultation on the design of analytical methods and pharmacokinetic studies and assistance with the analysis of PK data. The Specific Aims of the facility are: 1) to provide Knight members access to instrumentation that is maintained for small molecule analysis and includes LC-MS/MS and GC-MS instruments;2) to provide Knight members with a full service laboratory to develop analytical methods, prepare samples and provide data analysis for both clinical and basic science investigations;3) to provide Knight members with assistance in the design and interpretation of pharmacokinetic studies for both animal models and Phase 1 investigations.

Public health relevance
RELEVANCE (See instructions): The study of the absorption, distribution, metabolism and elimination of established and experimental drugs is essential to the Knight Cancer Institute's program of personalized medicine. The BPSR enables investigators to ask quantitative questions about small molecules in all phases of translational research.